MARTIN (NUVONURO)-HIT TO LEAD CHEMISTRY-ADMET ONLY- MCSP-HEAL

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.

The Contractor, in performance of work under this task order, shall
provide a full-service facility and staff who will support a medicinal chemistry program in the late Hit
to Lead (HTL) phase to provide in vitro absorption, distribution, metabolism, excretion and toxicology
(ADMET) support to characterize structural analogs to determine best preclinical candidate and to
provide compound logistics of storage and shipping to support the Contributor (Martin, NuvoNuro) in
developing a novel therapeutic effective in treating pain. The scope of this Medicinal Chemistry
Support Program (MCSP) task order shall be medicinal chemistry services under Performance Area 2:
Medicinal Chemistry Support, in support of preclinical drug discovery efforts supported by NIH,
NINDS and its Contributors.

Public health relevance
This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.